Talk With Me Baby: Leveraging Well-Child Care to Enhance the Early Home Language Environment

Project Summary / Abstract
The quality of early language interactions with parents and caregivers in early childhood has long-term
implications for a child’s social, economic, and physical heath. Differences in the home language environment
(HLE) are well established and cross all sociodemographic characteristics, although disparities
disproportionately affect infants and toddlers growing up in under-resourced communities. Although several
decades of research have identified evidence-based strategies that enhance the HLE and improve child
outcomes, they have failed to reduce population-level disparities in child language development and long-term
outcomes. The study proposed here utilizes Talk With Me Baby (TWMB) as a novel tool to increase language-
building interactions between parent/caregiver and child. Because TWMB is delivered in the primary care
setting (which reaches up to 98% of families with infants and toddlers), it is scalable, low-cost, and universal.
With TWMB, healthcare providers can embed evidence-based language promotion into their well-child care
(WCC) anticipatory guidance for all children age 0-3 years. TWMB builds on decades of well-controlled
language intervention efficacy trials and has been deployed clinically for 8+ years. Here we propose a type 1
hybrid effectiveness implementation trial to measure the impact of TWMB on gains in the HLE and subsequent
child language outcomes. The trial is both randomized and controlled across 2 sites: a TWMB intervention
group (8 clinics) and a care-as-usual control group (8 clinics). In TWMB clinics, providers and care teams will
be trained to deliver TWMB during all 2-24 month WCC visits. Across TWMB and control clinics, we will enroll
25 parent-child dyads in each clinic (n=400 total) prior to their 2-month WCC visit and follow them through their
24-month WCC visit. For Aim 1, we will measure the impact of TWMB on the HLE and child language
development using Language Environment Analysis (LENA, “talk pedometer” recordings), home video
recordings of parent-child interactions during daily routines, and standardized child language measures
(including parent-report and direct assessments that are available in English and Spanish). For Aim 2, we will
examine characteristics that moderate the efficacy of the language promotion intervention (TWMB) for families,
including family strengths and sociodemographic characteristics. We will also examine HLE dosage and parent
language promotion knowledge as mediators of child language outcomes. For Aim 3, guided by the
Consolidated Framework for Implementation Research (CFIR), we will use a mixed methods approach to
examine factors relevant for TWMB implementation. Providers and care team members will complete validated
surveys to assess the constructs of feasibility, acceptability and appropriateness, and then participate in semi-
structured interviews to provide qualitative data. We expect successful completion of these aims will result in
knowledge that will change the standard of pediatric well-child care to include systematic universal language
promotion that can optimize the developmental potential of all young children.

Public health relevance
Project Narrative Language-rich interactions with a parent or caregiver can serve as a protective factor for young children, by supporting their language development and other positive long-term outcomes, but existing interventions have not had the necessary reach to families who need this information the most. This study utilizes the primary care setting as a low cost, scalable way to deliver language promotion intervention. Specifically, we will test the effectiveness and explore implementation of language promotion intervention (Talk With Me Baby) that embeds within anticipatory guidance during pediatric well-child care to boost early language development and reduce long-term disparities in health, academic, and economic outcomes.